Genome-scale genetic perturbation of the APOE2 and APOE4 human interactomes

Abstract Alzheimer’s disease (AD), the fourth leading cause of death in developed countries and one of the most common forms of dementias, is known to have a strong genetic component. Late-­ onset AD (LOAD), which constitutes >99% of AD cases, has been estimated to be up to 80% heritable. The APOE allele is the most prominent genetic risk factor for LOAD, accounting for up to 30% of LOAD heritability, and appears to modulate AD risk in an isoform-­dependent manner: APOE4 is the major risk-­conferring genotype while APOE2 is protective of disease and positively associated with cognitive longevity. However, the mechanism by which APOE variants modulate risk for or protection from AD and their interaction with other genetic risk factors in mediating LOAD is still poorly understood. Functional perturbation to study how multiple genetic hits can collaborate to develop a genetic risk profile of LOAD would be highly valuable for identifying and prioritizing potential therapeutic pathways. To do this, we will first develop an in vitro co-­culture system for studying APOE2 and APOE4 variants in isogenic human ES cell-­ derived neurons and astrocytes. To understand the differential contribution of these two isoforms to neuronal death, we will employ genome-­scale CRISPR-­Cas9 screens for the systematic genetic interrogation of the APOE interactome. These experiments will be the first genetic screen looking at the role of APOE2 and APOE4 in a human model of neurodegeneration, a central phenotype of Alzheimer’s disease. We aim to identify key genes and pathways that mediate the systems-­level cellular and functional differences caused by APOE alleles that can protect from or drive neuronal atrophy. This will help provide insight into the underlying mechanisms of APOE-­mediated neurodegeneration and has the potential to provide novel targets for therapeutic intervention.

Public health relevance
Public Health Relevance Alzheimer’s disease (AD) is one of the most common forms of dementia and affects more than 35 million people worldwide, yet currently there are no effective treatments available;; for the majority (>99%) of AD cases, categorized as late- onset AD (LOAD), the APOE allele has consistently emerged as the most important genetic risk factor. However, the mechanism by which APOE variants modulate risk for or protection from AD is still relatively poorly understood. This work will develop and genetically manipulate human cell culture models of sporadic Alzheimer’s disease to identify genes that may interact with APOE to be protective of neurotoxicity, serving as an important first step to identify promising points of intervention for LOAD therapy.